Ready, set, then go: Rapid posttranslational induction of protein production by drug administration in vivo

ABSTRACT
The ability to rapidly induce fully active proteins of interest (POIs) upon drug administration anywhere in the body
would be widely useful for developmental biology, synthetic biology, and gene and cell therapies, but existing
drug-regulated protein activation methods have limitations in speed, dynamic range, generalizability across
proteins, and applicability across tissues. The overall goal of this proposal is to overcome these limitations by
developing a novel approach, named Split Protein Ligation Activated by Steroid Hormone (SPLASH), focusing
on achieving lower background, faster induction, and plug-and-play generalizability for diverse POIs.
The innovative design of SPLASH involves sequestering an intein-extein fusion with the T2 mutant of the
estrogen receptor hormone-binding domain (ERT2), so that 4-hydroxytamoxifen (4-OHT) can release it to trans-
spice with a complementing intein-extein fusion, resulting in the production of any POI. As an example, SPLASH
will be applied to improve the Cre recombinase, addressing issues of leakiness and low induced activity.
This work will leverage recent atomic-level understsanding of the steps in steroid hormone receptor
sequestration and release by heat-shock complexes, and recent advances in developing fast trans-splicing
inteins with broad extein sequence-specificity. SPLASH will be the first method to use a steroid hormone to
regulate trans-splicing, and will also introduce a transformative application for fast-splicing inteins.
SPLASH will be rationally generated and optimized in two Aims. Aim 1 will focus on generating a functional
SPLASH prototype by optimizing topologies, HBD-intein linkages, and intein split sites through bacterial-free
library construction and expression. Aim 2 will develop SPLASH-Cre to demonstrate SPLASH utility, evaluating
performance in vitro and in vivo using a bioluminescent Cre reporter, and comparing it with untagged Cre and
the existing Cre-ERT2.
Successful completion of this project will establish SPLASH as a robust method for creating proteins rapidly
upon drug administration, providing a versatile tool for basic research, synthetic biology, and gene and cell
therapies. The proposal aligns with the R21 focus on technology development, utilizing interdisciplinary
approaches and state-of-the-art knowledge to address a crucial need in biomedical research.

Public health relevance
PROJECT NARRATIVE This proposal aims to address leakiness, slowness, or poor activity of existing drug-regulated protein activation methods by introducing a novel approach for rapid drug-activated production of proteins of interest in any component of the body. The project strategically combines recent insights developments in the fields of structural biology and chemical biology to devise achieve low leakiness, fast induction, high activity, and generalizability across a wide range of proteins in a completely rational manner.